COMPARISON OF 3 RECOMBINANT HIV ENVELOPE VACCINES IN HIV INFECTED PATIENTS

The objectives of this study are to examine the response of HIV-1 infected individuals with <500 CD4 cells/mm3 to vaccination with different HIV-1 gp160 antigens; to determine the effect of vaccination on HIV specific immune responses including neutralization antbodies, and HIV-1 specific pro-liferative and cytotoxic T-cell (CTL) responses. The lab was used for recombinant DNA techniques.